NMR User Program at NMRFAM

PROJECT SUMMARY
The National Magnetic Resonance Facility at Madison (NMRFAM) provides timely and reliable access to mature
NMR technology for application to a wide array of biomedical research questions. NMRFAM has staff with
decades of experience in facility operation and maintenance, a dozen high-field NMR spectrometers equipped
with state-of-the-art probe technology, and facility infrastructure (ample space, uninterrupted power systems,
environmental control, helium recovery) second to none, and NMRFAM has been at the forefront of
standardization, data stewardship through FAIR (findable, accessible, interoperable and reusable) data
principles and dissemination of best practices to the community. Support through the NIGMS R24 program of
NMRFAM through the R24 mechanism at NIGMS would support broad access to this exceptional resource in
Madison to leverage economies of scale, including stable and efficient operation that maximizes data quality and
minimizes instrument down time, facilitating many types of experiments that scientists are not able to perform at
their home institutions. Furthermore, the proposed next generation user program improves the rigor and
reproducibility of NMR data collection through instrument quality control, standard operating procedures, new
sample standards for microcrystalline proteins and nucleic acids, membrane proteins and fibrils, including
development of approaches for dynamics and function as well as structure. NMRFAM staff provide an
exceptional level of service tailored to the needs of individual users and projects, serving arguably the broadest
user base of any NMR facility in the US. NMRFAM actively seeks to support diverse users through outreach
and user training opportunities (workshops, video tutorials, protocols) to teach users how to understand and
analyze their NMR data. NMRFAM has a goal of providing users more than spectra, and the facility provides
staff support and automation tools to return deliverables: i.e., scientific knowledge not only data. The NMRFAM
mission lowers barriers to NMR and maximizes the impact of the facility when users can successfully apply the
NMR data to answer their biological question of interest. NMRFAM has built a reputation as a top-level facility
for external users and this project will maintain affordable access to NMRFAM. NMRFAM staff will regularly
evaluate performance criteria and consult with the external advisory committee and facility users so that the
facility continues to remain at the cutting edge and meet the needs of its user base.

Public health relevance
PROJECT NARRATIVE The National Magnetic Resonance Facility at Madison (NMRFAM) research resource provides access to state- of-the-art solution and solid-state NMR technology to the biomedical research community, enabling facility users to leverage the power and diversity of NMR methods to study the structure, dynamics, function and interactions of large and small biomolecules. NMRFAM will continue to provide reliable and timely access to NMR instrumentation with excellent staff support for all phases of the NMR experience, in order to engage actively in experiment design well aligned with user objectives, to obtain the highest quality data possible and to commit to interpreting results to solve highly significant biomedical research problems that are best addressed by NMR.